Adjuvant effect of physical exercise on immune response to COVID-19 vaccination and interactions with stress

PROJECT SUMMARY / ABSTRACT
Vaccination is an effective public health measure, yet host factors including advanced age, sex, obesity,
physical or mental health status may influence vaccine efficacy. Adjuvants improve immunogenicity to
vaccination but often result in greater side effects. As an alternative to the inclusion of adjuvants in the vaccine
formulation, evidence suggests physical exercise performed at the time of immunization may serve as an
effective non-pharmacological approach with the potential for greater impact in individuals with suboptimal
immune response and reduced reactogenicity. The effect of host factors on immune response to SARS-CoV-2
and long-term protection remains to be established, and positive findings for an adjuvant-like effect of physical
exercise would have an immediate translational impact. However, major barriers to the implementation of
exercise are inconsistent findings and a gap in the knowledge of the mechanisms that underlie such effects. Our
recent publication shows that we have identified an exercise protocol that consistently increases antibody
response to vaccines that is reproducible across several different vaccines. This finding holds the potential to
transform vaccine efficacy and address questions on the breadth and durability of immune response and
underlying mechanisms. The goals of this application are to determine the extent to which physical exercise
exhibits an adjuvant-like effect across long-term antibody and T cell-mediated immune responses to COVID-19
mRNA-based vaccines and establish the degree of immune enhancement in individuals who may have
suboptimal vaccine response due to high psychological stress. An additional goal is to identify potential operative
mechanisms, and compelling preliminary data show promise for metabolism-related mechanisms, a new
direction in this field of study. Aim 1 will identify the extent to which a single exercise session applied at the time
of initial immunization shapes the magnitude, breadth, and durability of immune response to SARS-CoV-2 mRNA
vaccine. Outcome measures are serum anti-spike receptor-binding domain (RBD) IgG titer, neutralizing
antibody, antigen-specific CD4+ and CD8+ T cell response measured up to one-year post-immunization. Aim 2
will determine the influence of psychological stress on antibody and antigen-specific CD4+ and CD8+ T cell
immune response to SARS-CoV-2 immunization and the extent to which exercise may override any potential
effect of stress. Aim 3 will apply transcriptomic (RNA-Seq) and metabolomic (Raman) measures to identify
pathways by which exercise influences immune response to vaccination. The long-term goals of this research
direction are to refine and develop behavioral interventions that optimize immunity and more broadly apply the
findings learned with respect to critical pathways of immunogenicity to optimize vaccine development for
currently underserved populations.

Public health relevance
PROJECT NARRATIVE The objective of this research is to determine the extent to which a single session of exercise that takes place after receiving a SARS-CoV-2 mRNA-based vaccine (Pfizer or Moderna) may enhance immune response to the vaccine. A second goal is to determine how psychological stress impacts vaccine response. Finally, the potential pathways by which exercise influences immune response will be identified.